Genetic and phenotypic adaptations of vancomycin-resistant Enterococcus faecium during recurrent bloodstream infection

ABSTRACT
Enterococcus faecium is a normal member of the healthy human microbiota; however, it has become a
concerning opportunistic pathogen. E. faecium is resistant to many first-line antibiotics and most clinical isolates
are also vancomycin-resistant (VREfm), leaving high-risk patients with few treatment options. As such, infections
caused by VREfm are challenging to manage, and ~10% of patients with VREfm bloodstream infections will go
on to develop recurrent disease. It is largely unknown how VREfm adapts within its host to evade eradication by
standard antimicrobial therapies and cause recurrent infections, as few systematic genomic or phenotypic
assessments have been performed in VREfm. The first two aims of this proposal plan to address this important
knowledge gap by 1) comparative genomic analyses of VREfm bloodstream isolates collected from patients with
recurrent infections to find genetic signatures associated with the potential to resist eradication and cause
recurrence; and 2) determining the role of antibiotic tolerance in recurrent VREfm disease.
Bacteriophage (phage) therapy has the potential to provide clinicians with an additional tool for treating
challenging enterococcal infections, but transitioning phage therapy into clinical practice has been stymied by
the limited generalizability of small pre-clinical studies and the lack of pharmacokinetic-guided dosing regimens.
To address these limitations this proposal will 1) combine a broad-spectrum phage cocktail with VRE-targeting
antibiotics against the cohort of recurrent VREfm isolates proposed above to assess for phage-antibiotic
synergism and 2) develop a one-compartment pharmacokinetic model to determine optimal dosing strategies to
inform future clinical use. This collection of VREfm isolates will provide a representative cross-section of strains
likely to fail standard antibiotic therapies, and enable a thorough assessment of phage-antibiotic combinations
as potential treatment options for complex VREfm infections.
This K08 proposal is a five-year career development program for Madison Stellfox, MD, PhD that provides
dedicated research training under the guidance of an expert mentoring team to enhance her existing laboratory
and clinical background and provide additional instruction in the principles of comparative genomics, evolutionary
biology, pharmacology, and phage therapy. Dr. Stellfox is currently an infectious diseases fellow and postdoctoral
researcher in the laboratory of Dr. Van Tyne, and the resources and mentorship available at the University of
Pittsburgh and in the Van Tyne laboratory provide an ideal educational environment. Through the successful
execution of this training plan, Dr. Stellfox will gain the experience and guidance she needs to achieve her
aspirations of becoming an independent physician-scientist with a research program focused on the in-host
evolution of gram-positive bacteria during recurrent disease and the practical application of phage therapy for
difficult-to-treat enterococcal infections.

Public health relevance
PROJECT NARRATIVE Vancomycin-resistant Enterococcus faecium has become a concerning opportunistic pathogen known to cause recurrent infections in high-risk patients, and few antibiotics are available to treat this organism. We have limited knowledge regarding the bacterial genomic and phenotypic adaptations that arise within the human host during infection that lead to persistent and recurrent disease. This proposal outlines a training program designed to equip Dr. Stellfox with the essential skills in comparative genomics, evolutionary biology, phage biology, and pharmacology that are necessary to discover new bacterial cellular pathways associated with recurrent enterococcal bacteremia and evaluate the potential of bacteriophage-antibiotic combinations to combat challenging enterococcal infections.